Father-Infant and Mother-Infant Biobehavioral Coregulation in Families at Risk of Maltreatment

PROJECT SUMMARY/ ABSTRACT
Infant development is largely shaped by caregiver-infant interactions, and such interactions are often impaired
in families at risk of maltreatment. During healthy caregiver-infant interactions, caregivers and infants co-
construct physiological and behavioral exchanges – known as concordant coregulation – that are thought to
support infant adaptation to stress and serve as an important biomarker of risk. In maltreating families, this
coregulation manifests as discordance between caregiver and infant physiology and behavior, thereby
increasing vulnerability for poor infant development. While evidence suggests discordance in maltreating
mother-infant dyads – that is, a negative or absence of association of mother-infant coregulation over time –
the extent to which fathers can match their infant’s physiological and behavioral states remains unanswered.
Moreover, despite knowledge that fathers are often overrepresented as perpetrators of more severe forms of
maltreatment, we lack an advanced understanding of the role of fathers in exacerbating or protecting against
maltreatment risk as well as in shaping infant regulatory processes and developmental outcomes. This study
will be among the first to examine patterns of mother-infant versus father-infant biobehavioral coregulation
among families oversampled for risk. The goal of this study is to advance understanding of the etiology of child
maltreatment and infant development in terms of the role of individual and dyadic caregiver-infant regulation
and address the following aims: (1) examine patterns of coregulation among mother-infant versus father-infant
dyads, and (2) investigate the extent to which patterns of mother-infant versus father-infant coregulation affects
maltreatment risk and infant development. Study methods will involve a brief, longitudinal design with self-
report, observational, physiological, and behavioral assessments of 60 families from dual-caregiver households
with an infant between 6 to 9 months old. This study will have high impact because it will elucidate novel
dyadic biobehavioral processes and the role of fathers in affecting maltreatment risk and infant development.
Collectively, this work has translational implications for identifying mechanistic pathways to inform
maltreatment prevention and intervention programming to promote health and wellness among high-risk
caregiver-infant dyads.

Public health relevance
PROJECT NARRATIVE Infants are at highest risk for child maltreatment, which is a serious public health problem and is associated with negative consequences across the lifespan. To better inform maltreatment prevention, we need an advanced understanding of the role of both mothers and fathers in affecting maltreatment risk and infant development. Thus, the proposed research is relevant to NICHD’s mission because it will elucidate mother- infant and father-infant regulatory processes that may underlie maltreatment risk and its consequences, thereby identifying modifiable mechanistic pathways during a sensitive period to prevent maltreatment and promote the development of infants living in high-risk environments.